Intertectal input shapes visual circuit development and post injury remodeling

DESCRIPTION (provided by applicant): Neural circuits used in sensory processing must be stable enough to mediate survival-critical behaviors, and yet plastic enough to adapt to a dynamic environment. While great progress has been made in understanding how single synapses adjust response strength, less is known about the mechanisms of circuit-level development and plasticity. In the proposed study, I will use electrophysiology to investigate the connections between the two hemispheres of the Xenopus optic tectum, and their role in circuit plasticity and maturation, both in the course of normal development and in response to injury. These connections are poorly understood, and their contribution to circuit development and plasticity is unknown. The optic tectum is homologous to the mammalian superior colliculus and is critical for processing sensory information from multiple modalities. These intertectal inputs are tectal neurons which extend axons across the commissure to synapse onto tectal neurons in the contralateral hemisphere. In the superior colliculus, it has been proposed that these inputs mediate reciprocal inhibition; however the cellular and circuit-level mechanisms underlying this function are unknown. We have developed a new dissection prep in order to allow us to specifically explore 1) how intertectal inputs develop in Xenopus and how these inputs contribute to circuit formation, 2) how changes in the strength of intertectal input affects retinotectal circuit formation and plasticity and, 3) the remodeling of these inputs, and their contribution to recovery post-injury. These experiments will not only address fundamental questions of how neural circuits are formed and maintained, but will provide crucial information on changes that occur in disease states wherein synaptic connectivity is disrupted, such as schizophrenia, stroke, and traumatic brain injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project will investigate fundamental mechanisms of how convergent synaptic connections within neural networks are formed and maintained. Understanding how these connections are made will inform our ability to treat diseases in which synaptic connectivity is disrupted, such as schizophrenia, autism, and traumatic brain injury. __SpecificAimsTextDelimiter__ Specific Aims In order for an organism to function within its environment, it must successfully translate sensory input into an appropriate behavioral output. This process relies on the activation of specific synaptic connections, both in series and in parallel, to successfully and efficiently transfer and process information. These neural circuits must be stable enough to consistently mediate such survival-critical behaviors as escape from predators and identifying food, and yet retain a degree of plasticity such that the organism can adapt to dynamic environmental conditions. The importance of sensory input in shaping the development and plasticity of neural circuitry has been described in many systems. However, it is less well understood how convergent inputs from multiple brain regions affect the development, plasticity and function of complex circuits. The superior colliculus, or its homolog in non-mammalian vertebrates, the optic tectum, receives and processes multimodal sensory inputs and governs motor outputs. In addition, each optic tectal lobe receives input from neurons located in the contralateral tectum and pretectal area which extend axons across the inter-tectal commissure. Although we have considerable understanding of the function of the retinotectal circuitry in receiving and processing visual information, the potential role of the intertectal connections in shaping visual responses and visually-guided behavior is not known. I propose to use electrophysiological techniques combined with molecular genetic manipulations of neuronal activity and synaptic transmission to characterize this set of inputs, to test whether activation of intertectal inputs convergent with retinal stimuli shapes the development and plasticity of the tectal circuitry, and to use an injury/recovery model to study both the requirement of intertectal communication for visually-guided behavior in Xenopus tadpoles and how these inputs function in circuit repair after injury. Specific Aim 1: To characterize the development of intertectal inputs in Xenopus. I will use electrophysiological techniques to determine the properties of excitatory intertectal inputs at 2 time-points of tadpole development corresponding to times before and after use of the visuo-motor system to forage for food and avoid predators. Using the isolated tadpole brain preparation, I will test whether the ionotropic glutamatergic intertectal inputs mature through a sequential shift in the AMPA/NMDA ratio of synaptic currents, and whether these changes are accompanied by shifts in receptor subunit composition and the probability of release. These experiments will lay the foundation for testing the potential role of intertectal inputs in the development and function of the visual circuit, as described below. Specific Aim 2: To determine the effect of modulating intertectal input on normal circuit development and plasticity. Based on our preliminary observations that cutting the inter-tectal commissure prevents visually-guided behavior, I postulate that the intertectal connections modulate retinotectal inputs and affect visual responses in tectal neurons. In this aim I will increase or decrease the activity of intertectal inputs using several molecular genetic methods to control firing or synaptic release, and test the effects of these manipulations on the development and plasticity of retinotectal and intertectal connections. In addition, I will record from tectal neurons in the isolated brain preparation to test whether spike-timing dependent plasticity protocols applied to convergent intertectal and retinotectal inputs affect the maturation and/or the plasticity of intertectal and retinotectal inputs. Finally, I will test whether intertectal inputs modulate visual responses in intact animals. Specific Aim 3: To use localized brain injury to determine how intertectal input contributes to optic tectum-dependent behavior. We have shown that intertectal communication is crucial for mediating visual avoidance behavior in tadpoles. To elaborate on how intertectal input shapes visuomotor behavior in the functioning organism, I will use a local brain injury paradigm recently established in the lab. Injured animals lose the ability to detect and avoid an oncoming visual stimulus, but recover the visual avoidance behavior ~7 days after injury. Our recent work has shown that recovery is facilitated by neurogenesis. Here I will test whether intertectal inputs enhance incorporation of new neurons into the damaged circuit and whether manipulations of intertectal activity speed or retard recovery of the visual avoidance behavior.